DNA Damage and Response in the Bladder Microenvironment.

DESCRIPTION (provided by applicant): Bladder augmentations using gastrointestinal tisue are frequently performed in children with complex urogenital anomalies. The gastrointestinal tissues in an augmented bladder are significantly more likely to develop cancer than the native bladder tissue, although the mechanisms leading to this risk are not known. High urinary concentrations of urea and other substances contribute to a hyperosmolal bladder microenvironment, and we have recently shown that this hyperosmolal stress disrupts gastrointestinal cell DNA damage signaling and repair. Our central hypothesis is that the hyperosmolal bladder microenvironment impedes the detection and repair of DNA damage in susceptible tissues such as the gastrointestinal portion of an augmented bladder, leading to mutagenesis and ultimately carcinogenesis. The Candidate's immediate goals are to investigate these biological processes in a bladder microenvironment through both in vitro and in vivo models of bladder augmentation, and to further his formal scientific training through didactic instruction and mentored laboratory experience. The Candidate's long-term goals are to explore the translational aspect of this work in clinical trials aimed at the reduction of bladder cancer in patients with bladder augmentations and to become an independent investigator in the broad field of DNA damage and repair as it pertains to the lower urinary tract. The Candidate and his co-mentors, Drs. Peter Stambrook and John Bissler, have developed a comprehensive career development plan with four key components: laboratory experimentation; mentored oversight; didactic instruction through seminars, additional graduate coursework, and training in grant-writing and manuscript preparation; and clinical participation with pediatric urologists in the care of patients with bladder augmentations at Cincinnati Children's Hospital Medical Center (CCHMC). This career development plan will provide the Candidate with the skills and tools necessary to launch an independent research career, with specific translational impact on children with bladder augmentations. The environment at CCHMC and the University of Cincinnati (UC) College of Medicine is highly supportive of the Candidate in the early portion of his research career. Both institutions offer a wealth of resources, both physical and intellectual, that will help foster the Candidate's research career development. These include a number of core facilities directly relevant to this project such as the flow cytometry core, mass spectrometry core, and vivarium at CCHMC as well as numerous faculty members in the Division of Experimental Hematology and Cancer Biology at CCHMC and the Departments of Cancer and Cell Biology and Molecular Genetics, Biochemistry & Microbiology at UC with specifically relevant research interests to the Candidate's project and area of research focus. The research plan described in this application has three Specific Aims: to measure the effects of a hyperosmolal bladder microenvironment on the DNA damage response pathway, to assess the efficacy of DNA repair under a hyperosmolal bladder microenvironment, and to evaluate the activation of cell cycle checkpoints and apoptosis following DNA damage within a hyperosmolal bladder microenvironment. Each of these aims will be investigated in both in vitro and in vivo models of bladder augmentation. In the in vitro portion of these experiments, gastric, colon, small intestine, and bladder epithelial cell lines from the H-2Kb- tsA58 mouse will be gradually adapted to hyperosmolal conditions with sodium chloride or urea, or maintained in isoosmolal conditions, then exposed to different forms of DNA damage. DNA damage will be measured by techniques dependent on the type of DNA damage lesion induced. Activation of the DNA damage response pathway will be evaluated by western blot. The kinetics of DNA repair will be assessed by serial comet assays, and the activity of different DNA repair mechanisms will be assessed by coimmunoprecipitation and immunofluorescence. Cell cycle checkpoint activation will be determined by flow cytometry and by western blot for activation of cell cycle checkpoint proteins. Activation of apoptosis will be quantified by western blot, as well as annexin V binding through flow cytometry. In the in vivo portion of these experiments, we will perform bladder augmentations using stomach, small intestine, or colon tissue as well as sham operations in Sprague Dawley rats. At sequential time points following surgery, the animals will be sacrificed and the gastrointestinal and native bladder tissues will be examined histologically for metaplasia and dysplasia. The tissues will be analyzed for DNA damage using the TUNEL and PANT assays; for activation of the DNA damage response, cell cycle checkpoints, and apoptosis through immunohistochemistry; and activation of DNA repair through EdU labeling.

Public health relevance
PUBLIC HEALTH RELEVANCE: Exposure of cells inside the bladder to high concentrations of waste products like urea, which are normally present in the urine, can interfere with the ability of the body to recognize and repair damage to its genetic code. This may lead to cancer of the bladder, especially in children who have their bladders surgically reconstructed. PROJECT NARRATIVE Relevance Exposure of cells inside the bladder to high concentrations of waste products like urea, which are normaly present in the urine, can interfere with the ability of the body to recognize and repair damage to its genetic code. This may lead to cancer of the bladder, especially in children who have their bladders surgically reconstructed. __SpecificAimsTextDelimiter__ RESEARCH PLAN 10. SPECIFIC AIMS The lower urinary tract epithelium is uniquely adapted to withstand the wide changes in urinary osmolarity. Cells that are maladapted to this microenvironment may experience osmotic stress, resulting in disruptions in both cel cycle control and the DNA damage response. Children with complex urogenital anomalies often require bladder reconstruction with non-native bladder tissues to create a more compliant, low-pressure reservoir. At present, bladder augmentations generally utilize gastrointestinal tisues and it is becoming apparent that these tissues, in the bladder microenvironment, are at significantly increased risk of malignancy. Future strategies involving the use of synthetic scaffolding materials may also be negatively impacted by the bladder microenvironment, because epithelialization would require proliferation and migration of urothelial cells across the synthetic surface, exposing proliferating cels to hyperosmolal conditions. The efect of the hyperosmolal bladder microenvironment on the cell cycle control, DNA damage response, and other vital cellular processes of gastrointestinal and other non-native bladder tissues is not known. The central hypothesis of this application is that within the bladder microenvironment, DNA damage response, DNA repair, cell cycle control, and apoptotic signaling are dysregulated in susceptible tissues leading to mutagenesis. The goal of this project is to study the effect of the hyperosmolal bladder microenvironment on these processes in native urinary tract tissues, as well as non- native bladder tissues from the gastrointestinal tract and bioengineered materials. To accomplish this goal, the Candidate will use a series of cell-based and rat in vivo model experiments in the following aims: 1. To measure the effects of a hyperosmolal bladder microenvironment on the DNA damage response pathway. We will induce a variety of DNA damage types in conditionally immortalized gastrointestinal and urothelial cell lines gradually adapted to hyperosmolar conditions and grown on standard cell culture surfaces as well as on synthetic scaffolding materials. DNA damage will be measured using comet assays, and DNA damage response proteins will be evaluated by western blot. To explore the DNA damage response pathway in vivo, we will perform gastrocystoplasties, ileocystoplasties, and colocystoplasties on rats and the animals' water intake will be manipulated to generate either a typical or dilute urine osmolarity. Oxidative DNA damage occurs spontaneously in the hyperosmolal bladder microenvironment, but DNA damage may also be induced using a urinary alkylating agent and carcinogen such as BBN. Metaplasia, dysplasia, and malignant changes will be assessed histologically, DNA damage will be assayed using the TUNEL and PANT assays, and the DNA damage response will be measured by immunohistochemistry. 2. To assess the efficacy of DNA repair under a hyperosmolal bladder microenvironment. Using the cell lines, conditions, and DNA damaging agents above, we will assess DNA damage repair kinetics in the cell-based experiments using comet assays, coimmunoprecipitation and foci immunofluorescence for cells grown on both standard cell culture surfaces and synthetic scaffolding materials. For the animal experimentation, DNA repair will be followed using EdU labeling and interaction of DNA repair proteins will be studied by immunofluorescence foci detection. 3. To evaluate the activation of cell cycle checkpoints and apoptosis following DNA damage under a hyperosmolal bladder microenvironment. Cell cycle checkpoint activation in the cell-based experiments will be assessed using flow cytometry and immunoblotting for the cells grown under the conditions above. Activation of apoptosis will be evaluated with flow cytometric measurement of annexin V binding as well as western blot analysis of the release of cytochrome c from the mitochondria and caspase activation. We will examine the animal model tissues for both mitotic activity and apoptosis by immunohistochemistry and histology. The findings from these proposed investigations will greatly advance the understanding of the tissue/environment interaction that places gastrointestinal and possibly synthetic bladder augmentations at greater risk for malignancy. Perhaps more importantly, the results of these studies will also offer novel therapeutic interventions to prevent cancer of the gastrointestinal and synthetic urothelial tissues in the augmented bladder, for example by judicious use of a V2R antagonist such as tolvaptan to eliminate the medullary concentration gradient, thereby maintaining an isoosmolal urinary environment in such patients. Furthermore, these outcomes are expected to position the Candidate to submit a competitive R01 application for independent research funding in the latter two years of this award.